Administrative Core

REVISED PROJECT SUMMARY - ADMINISTRATIVE CORE The Mayo Clinic ADRC will pursue the theme of Multiple Etiology Dementias, as emphasized in the 2022 Alzheimer’s Disease and Related Disorders Summit. Toward that goal, the ADRC will continue its current efforts to support research in Alzheimer’s disease (AD), frontotemporal lobar degeneration (FTLD) and Lewy body disorders disease (LBD) spectrum disorders, and in conjunction with other new programs, add vascular cognitive impairment dementia (VCID), to the neurodegenerative diseases. The Center will focus on the recruitment of an African American/Black cohort, a Hispanic/Latino cohort, and participants from Rural Dwelling areas. The Center will continue activities through the existing Administrative, Clinical, Data Management and Statistical, Neuropathology, Outreach, Recruitment and Engagement, Biomarker, and Neuroimaging Cores, and the Research Education Component (REC). We will be adding two new Cores in this application. The Genomics Core will focus on genetic and -omics aspects of the various neurodegenerative diseases and has already established a strong foundation in the various disorders with numerous additional grants. The Digital Innovation Core will combine techniques involving neuroimaging, gait assessments, speech/language and remote cognitive screening to also pursue the theme of the Center. The Administrative Core of the Mayo Clinic ADRC will oversee all activities of the Center. The Mayo Clinic ADRC operates in Mayo Clinic Rochester (MCR) and Mayo Clinic Florida (MCF) in Jacksonville, Florida. It has functioned seamlessly for 33 years and, with the assistance of institutional support from the Mayo Clinic, has operated as a single Center. The Administrative Core of the ADRC performs liaison activities with Executive Dean for Research at Mayo Clinic and with the National Institute on Aging. The Core holds regularly scheduled meetings of the Core Leaders of the ADRC and maintains communication among the faculty. As described in this and multiple other Cores, succession plans are in place to transition many of the Core Co-leads over the next cycle, if funded. Resource sharing with national repositories and external investigators; engagement of investigators, trainees and participants of URG backgrounds; and training the next generation of investigators devoted to AD/ADRD research, will continue as high priorities for the Center – to be coordinated by the Administrative Core and associated Cores and REC.